Role of VPS4A and ESCRT-III in terminal erythropoiesis

Project Summary
Congenital dyserythropoietic anemias (CDAs) are a heterogeneous group of genetic disorders characterized by
ineffective erythropoiesis, hemolysis, and bi- or multi-nucleated erythroblasts in the bone marrow. The
mechanisms of erythroid dysfunction in CDAs are incompletely understood; studying the molecular defects in
these diseases can reveal critical pathways in terminal erythropoiesis. We have identified mutations in VPS4A
as a novel cause of CDA in three unrelated patients with a syndrome of dyserythropoiesis, hemolytic anemia,
and neurodevelopmental delay, pointing to the importance of Vacuolar Protein Sorting 4A (VPS4A) for terminal
erythropoiesis and normal red blood cell survival. However, the mechanisms of its action need further
investigation. VPS4A is an ATPase that has been shown in yeast and in vitro cell cultures to participate with the
Endosomal Sorting Complex Required for Transport (ESCRT)-III in endosomal vesicle trafficking, viral budding,
and the abscission step of cytokinesis. It is required for budding of endosomal vesicles into multivesicular bodies,
a critical step in the pathway for the sorting, recycling, and removal of transmembrane protein receptors. We
have shown for the first time a human disease in patients with dominant negative mutations in the ATPase
domain of VPS4A, resulting in dyserythropoiesis with erythroblasts connected by cytoplasmic bridges consistent
with cytokinesis failure at the abscission step and reticulocytes with evidence of altered trafficking of the
transferrin receptor (TfR1/CD71). We hypothesize that VPS4A is essential for terminal erythropoiesis and that
loss of function results in dyserythropoiesis through a combination of cytokinesis failure and endolysosomal
defects. The goal of this work is to define the molecular mechanisms by which these VPS4A variants disturb
erythropoiesis, and to elucidate the roles of VPS4A and the ESCRT machinery in human and murine terminal
erythropoiesis. We aim to model the erythroid defects due to VPS4 in vivo using a transgenic mouse model with
erythroid-targeted expression of a known dominant-negative VPS4 mutant (VPS4EQ), enabling studies on the
pathogenic mechanisms and natural history of the disease (Aim 1). Using human iPSCs, we will investigate the
contributions of cytokinesis failure and iron trafficking defects to the dyserythropoiesis observed in these
individuals using normal, patient-derived, and VPS4AEQ CRISPR gene-edited iPSCs (Aim 2). These studies will
demonstrate the role of VPS4A and ESCRT-III machinery as an essential molecular pathway for erythropoiesis.

Public health relevance
Project Narrative Congenital dyserythropoietic anemias (CDAs) are a group of blood disorders in which erythropoiesis, the production of red blood cells, is impaired. Inherited and de novo mutations in the gene VPS4A have recently been identified to be a cause of CDA suggesting a specific requirement for VPS4A function in erythropoiesis. This proposal aims to identify the mechanisms by which VPS4A mutations cause this disease and will reveal a new pathway essential for erythropoiesis enhancing our understanding of both CDA pathogenesis and normal red cell development.